Lipid and metabolic mechanisms responsible for phosgene and phosphorus trichloride exposure toxicity

Exposures to phosgene (COCl2) and phosphorous trichloride (PCl3) are public health threats. COCl2 and PCl3
exposures are the result of industrial accidents or chemical warfare/terrorism acts. Following exposures, acute
lung injury presenting as apnea and pulmonary edema are major concerns, which contribute to mortality and
morbidity. However, mechanisms responsible for the action of these pulmonary toxic agents have not been
elucidated. Both COCl2 and PCl3 rapidly produce HCl in the lung. Plasmalogen phospholipids including
plasmenylethanolamine (pPE) in the lung are acid-labile leading to the production of lipidic aldehydes and
lysophosphatidylethanolamine containing polyunsaturated fatty acids (PUFA-LPE). In addition to COCl2 and PCl3
reacting with the vinyl ether bond of plasmalogens, other functional groups of lipids may also be targeted. These
include primary amines and conjugated dienes suggesting that an array of lipophilic compounds is produced
during exposures. Functional groups of proteins and metabolites may also be modified by COCl2 and PCl3
exposures leading to metabolic alterations. Extensive discovery omics analyses following exposures to COCl2
and PCl3 will provide critical insights into mechanisms responsible for their toxicity. We hypothesize that both
COCl2 and PCl3 exposures result in lipid and metabolic changes leading to endothelial and epithelial cell
dysfunction. Both targeted and untargeted approaches will be performed to identify novel lipidic and metabolic
changes following COCl2 and PCl3 exposures. In support of this hypothesis, pilot data show: 1) PUFA-LPE levels
are elevated in response to PCl3 exposure to primary human lung microvascular endothelial cells (HLMVEC); 2)
PUFA-LPE elicits HLMVEC barrier dysfunction; 3) COCl2 exposure to lung lipids results in the production of a
family of lipophilic aldehydes and 4) PCl3 elicits profound changes in HLMVEC metabolites and metabolic
pathways following exposure. There are two specific aims for the proposed studies. Specific Aim 1 will
identify novel lipid and metabolic products following COCl2 and PCl3 exposures resulting in endothelial and
epithelial cell dysfunction. Specific Aim 2 will identify mechanisms by which novel lipid and metabolic species
produced following COCl2 and PCl3 exposures elicit endothelial and epithelial cell dysfunction.
We will investigate COCl2 and PCl3 exposures to both primary human lung microvascular endothelial cells and
primary human small airway epithelial cells. This, together with testing these two distinct toxicants at LD50 levels,
meet criteria for this RFA. The proposed studies will examine a potential common mechanism for COCl2 and
PCl3 toxicity mediated by PUFA-LPE. Additionally, unique lipid and metabolic changes will be examined following
COCl2 and PCl3 exposures using untargeted analytical approaches. Collectively, these studies will provide in-
sights into the mechanisms responsible for toxicity and will provide therapeutic targets for the development of
countermeasures to COCl2 and PCl3.

Public health relevance
The proposed studies will demonstrate a shared mechanism for phosgene and phosphorus trichloride toxicity mediated by degradation of plasmalogen phospholipids, which will be tested as a mechanism responsible for barrier dysfunction in endothelium and epithelium. Additional untargeted omics approaches will be employed to discover additional mediators and mechanisms. These studies may provide targets for therapeutic countermeasures to phosgene and phosphorus trichloride exposures.